A rapid CRISPR-based self-testing platform for early detection of HIV

PROJECT ABSTRACT/SUMMARY
In 2018 alone, the WHO reported 1.7 million new cases and estimated 770,000 HIV-related deaths due
to gaps in HIV services. Early detection of HIV would allow quicker intervention and can significantly reduce the
risk of death and further transmission. Therefore, this proposal aims to develop an innovative engineered
CRISPR/Cas-based automated self-testing diagnostic platform for early detection of HIV RNA. The type
V and VI CRISPR/Cas systems when bound with their specific target sequence, activate a secondary collateral
nuclease activity that can rapidly cleave single-stranded nucleic acids in a non-specific multiple-turnover manner.
By monitoring the collateral activity of CRISPR/Cas systems using a FRET-based reporter, picomolar
concentrations of a target can be detected. Jain lab (PI) discovered that 3'-end extensions of CRISPR RNAs
with a short 7-nt DNA, drastically enhances the collateral nuclease activity of LbCas12a by 3.2-fold and termed
it ENHANCE. By applying ENHANCE femtomolar concentrations (700 fM) of HIV-1 target gene was detected in
30 min without requiring any target pre-amplification (Nat. Comms., 2020 & Methods, 2021). The Jain lab
developed a lyophilized version of ENHANCE v2, which is stable up to 30 days at room temperature and in
combination with an isothermal DNA amplification step, achieved a limit of detection of 15 copies/µL of SARS-
CoV-2 RNA with ~97% sensitivity and ~97% specificity in patient samples within 50 minutes (Comms. Med.,
2022). The PI recently developed a thermophilic BrCas12b-based single-pot SPADE assay to detect SARS-
CoV-2 in saliva using a point-of-care device (eBioMed., 2022) and an engineered BrCas12b-based SPLENDID
assay to detect HCV RNA in serum extracted with magnetic beads (Cell Rep. Med.-in revision, 2023).
Based on the preliminary data, the exploratory R61 phase will have the following specific goals. 1) To
enhance sensitivity and specificity of CRISPR/Cas systems to detect 1000 copies of RNA in 1 mL of plasma
without the need for an isothermal DNA amplification step. 2) To develop an automated integrated microfluidic
device for sample preparation, extraction, and detection of a HIV-1 target by naked eye at 1000 target copies/mL
concentration. 3) To perform a pilot study with the optimized device for validating HIV-1 RNA detection in clinical
plasma samples from healthy (n=60), and HIV-infected (n=60) with 95% accuracy. Only after achieving these
milestones, the project will transition into the R33 phase with the following specific aims: 1) To recruit and survey
200 participants for user acceptability and usability of the device. 2) To perform clinical assessment of the self-
testing platform with 200 participants. This integrated approach will have all the components as defined by the
ASSURED (Affordable, Sensitive, Specific, User-friendly, Rapid and robust, Equipment-free and Deliverable to
end-users) criteria by WHO. The development of this rapid self-testing platform would allow quicker interventions,
reduced outbreak and ultimately reduced deaths in people infected with HIV.

Public health relevance
PROJECT NARRATIVE Early detection of HIV using a self-testing kit at home can save lives of millions of HIV-infected patients and their partners by enabling early intervention and treatment options preventing spreading and maturation to AIDS. This project defines a novel approach to detect HIV RNA based on engineered CRISPR/Cas12a system coupled with an automated microfluidic-based device. To make it amenable to the resource-constrained settings, our proposed diagnostic approach will follow the ASSURED (Affordable, Sensitive, Specific, User-friendly, Rapid and robust, Equipment-free and Deliverable to end-users) criteria as recommended by the World Health Organization.